FOR OPTION PERIOD 1: EXERCISE OPTION PERIOD 1; AND 2) FUND 3 ADDITIONAL CASES; FOR OPTIONAL QUANTITY 1 WITHIN EXERCISE OPTION PERIOD 1; AND 2) FUND 77 ADDITIONAL CASES.

The contractor collected biospecimens included tumor tissue, normal tissue, and blood according to an NCI-provided protocol. The biospecimens were used for proteogenomic characterization studies. The contractor collected corresponding clinical data including medical history, demographic information, diagnostic data, and annual follow-up reports.